FDA Vet-LIRN Infrastructure Support for Ohio ADDL

This proposal from the Ohio Department of Agriculture (ODA) is in response to Funding
Opportunity Announcement (FOA) PAR-22-063 from the Food and Drug Administration
(FDA) Center for Veterinary Medicine (CVM) Veterinary Laboratory Investigation and
Response Network (Vet-LIRN). The project is titled “FDA Vet-LIRN Infrastructure Support
for Ohio ADDL.”
This proposal from ODA’s Animal Disease Diagnostic Laboratory (ADDL) addresses the
following key project areas:
1. Participation in FDA/Vet-LIRN sample analysis. Samples could be collected by
Federal, State, or local entities.
2. Providing analytical data to support potential regulatory use through:
a. Use of standardized methods, equipment platforms, and reporting methods
(standardized analytical worksheets and electronic results reporting).
b. Participation in proficiency testing and method training provided by the
VPO.
c. Investigating consumer report cases requested by VPO
d. Implementation of standardized quality management systems for
laboratories as determined by the VPO.
3. Participation in additional research and special projects such as small-scale
method development and/or method validation and matrix extension work as
determined by the VPO.
The ADDL is prepared to strengthen coordination of veterinary diagnostic laboratory
efforts as related to the national food safety system by supporting research and capacity
building during case investigations, including chemical, microbiological, pathological, or
other complex analyses to help determine cases of potential adulteration or contamination
of animal foods or animal drugs. Specifically, this grant opportunity supports the ability of
network laboratories to respond to case investigation needs. This includes support for
training, quality assurance processes, proficiency exercises, and data sharing to support
development of veterinary diagnostic laboratories. The ADDL also plans to utilize funds
to expand its ISO 17025 scope to achieve these goals.

Public health relevance
FDA CVM Vet-LIRN PROGRAM (U18) GRANT PROPOSAL FOR FOA # PAR-22-063 from the OHIO DEPARTMENT OF AGRICULTURE, ANIMAL DISEASE DIAGNOSTIC LABORATORY PROJECT NARRATIVE The FDA Veterinary Laboratory Investigation and Response Network (Vet-LIRN) enables analyses of animal diagnostic samples and animal food/drug products. Through Vet-LIRN, the FDA leverages the expertise of a national network of veterinary diagnostic laboratories to provide additional capability and capacity to strengthen the overall national food safety system. The Ohio Animal Disease Diagnostic Laboratory (ADDL) will offer its expertise and services to support testing and surveillance projects under direction from Vet-LIRN, provide surge capacities for testing using standardized Vet-LIRN methods, and assist Vet-LIRN with emergency response testing.